ELECTRICAL STIMULATION IN PATIENTS WITH HCM AT RISK FOR SUDDEN DEATH

Of 15 patients enrolled in the electrophysiologic protocol for management of patients at high risk for lethal arrhythmias in hypertrophic cardiomyopathy, 4 (27%) have had ventricular tachycardia induced in the absence of medications. Two additional patients exhibited a pro-arrhythmic effect to a Type 1A anti-arrhythmic. Abnormal AV nodal function has been found in 4 patients, and abnormal sinus node function in 2 patients. Re-entrant arrhythmias have been documented in 2 patients, one of whom also had an atrial-ventricular bypass tract.